Agricultural Safety & Health Council of America (ASHCA) Research to Practice to Research (R2P2R) Events

ABSTRACT
The Agricultural Safety and Health (ASHCA) will convene a series of Research to Practice to Research
(R2P2R) topic-specific workshops and national conferences. ASHCA initiated a R2P2R pillar during its
2023 strategic planning to “Connect research and industry to proactively collaborate in bringing best
safety and health management practices to agriculture.” The proposed initiative herein aligns with the
strategic activities of the NORA Agriculture, Forestry, and Fishing Sector Council: 1) Plan, execute, and
conduct follow-up activities for a series of topic-specific R2P2R workshops and every-other year national
conference; 2) Facilitate public-private partnerships that build a culture of safety, promoting best ag
safety practices apace with evolving food production and worker profiles; 3) Identify research priorities
for NIOSH and the NIOSH-funded agricultural research centers based upon industry’s current
safety/health issues and anticipated future needs; and 4) Publish proceedings, commentaries, and
research studies in a dedicated issue of the Journal of Agromedicine.
ASHCA, through sponsorship of workshops and co-sponsorship with NFMC for national conferences,
envisions a comprehensive process with long-term implications. The initiative brings together diverse
stakeholders—from farm operators to governmental agencies—to discuss safety topics, uncover proven
prevention measures, and pinpoint crucial research needs. A special feature will extend support to
include under-represented participants reflecting the diversity of workers and occupational hazards in
modern agriculture. Tangible outputs, produced from workshops and conferences, include industry-
driven research priorities and online safety resources. This will lay the foundation for a robust, long-term
strategy poised to extend beyond the grant cycle. Post-grant evaluation will critically focus on the
R2P2R strategy, linked with ASHCA’s AgSharpe certificate program for early career safety managers.
The ultimate goal of this initiative is to sustain a culture of safety across U.S. agriculture – safeguarding
workers and their families, while augmenting the business success of large and small agricultural
producers. The envisaged R2P2R events, propelled by the joint commitment of industry, academia,
research, and safety advocates, hold the transformative potential to elevate the profile of safety,
fostering collaborations between industry experts and researchers. The experienced and passionate
team behind this grant application is poised and eager to propel the proposed R2P2R strategies into
action, marking a pivotal step towards a safer and more sustainable future for U.S. agriculture.

Public health relevance
NARRATIVE Bryan Weichelt, PhD of the National Farm Medicine Center (NFMC) is Principal Investigator and will co-chair activities with Paul Riley, Board Chair of the Agricultural Safety and Health Council of America (ASHCA). Both organizations have extensive experience in conference and workshop hosting; and the NFMC is home of the Journal of Agromedicine which will publish abstracts, research, commentaries, and brief reports from the events. The planned series of R2P2R topic-specific workshops and National Conferences (2025, 2027) is consistent with goals of the NORA Agriculture, Forestry and Fishing Sector Council, and NIOSH personnel will be involved in planning and implementation of events to maximize opportunities for achieving NORA goals.